Core B: MPN-RC Tissue Bank

Abstract
Core B, Tissue Bank provides the infrastructure to transport, receive, process, store, and
distribute tissue specimens obtained from patients with myeloproliferative neoplasms (MPN) as
well as patients enrolled on clinical trials (Project 4). These specimens are provided to MPN-RC
investigators performing translational research for the purpose of developing innovative
therapies (Projects1-3) and to the Biomarker & Bioinformatics Core D to perform biomarker
analyses to evaluate the effectiveness of specific therapies to deplete MPN hematopoietic stem
and progenitor cells (HSC/HPC). Tissues are also available to members of the scientific
community at large for translational research. Translational research is dependent on the ready
availability of tissues from a sufficient number of accurately diagnosed patients to generate
statistically significant data. Because the MPNs are relatively uncommon and their accurate
diagnosis can be difficult, there has been a paucity of tissue, linked to clinical data, available to
individual investigators at single institutions. Core B fills this void. With an inventory of more
than 15000 specimens from more than 1500 individual patients with MPNs, Core B maintains
one of the world's largest inventories of MPN tissues available for research. In addition, Core B
collects specimens from patients participating in MPN-RC sponsored clinical trials (Project 4) for
the purpose of performing biomarker studies to demonstrate the effectiveness of specific
therapies on the depletion of MPN hematopoietic stem and progenitor cells (HSC/HPC). The
specific aims of Tissue Bank Core B are to: 1) Receive, process, cryopreserve, and store
tissues from MPN patients as well as patients enrolled on clinical trials (Project 4) at MPN-RC
clinical sites; 2) Provide a central repository for MPN tissues that are associated with basic data
stored in the web-based data bank maintained by Biostatistics and Data Management Core C
including clinical, and laboratory data that enable selection and distribution of tissues best suited
for each translational research project; 3) Distribute tissues to: MPN Consortium investigators
for translational research to develop innovative therapies; MPN Consortium investigators to
analyze biomarkers to determine therapeutic and pharmacodynamic response to therapy as
well as to predict disease progression; and scientific community at large for translational
research. Tissues are available to members of the MPN Research Consortium (MPN-RC) and
to the scientific community at large for the performance of translational research. Core B is an
essential shared resource that enables translational research that will ultimately lead to the
development of molecularly targeted therapies.

Public health relevance
Project Narrative MPN-RC investigators are performing translational research in order to develop treatments and cures for myeloproliferative neoplasms (MPN) which are blood cancers. This research requires tissue specimens from patients with these diseases. MPN patients donate blood, bone marrow and spleen tissue to be used for research. The tissues are shipped to Core B Tissue Bank where they are processed, stored and then distributed to scientists for research purposes.